Opioid-induced potentiation of the exercise pressor reflex via acid-sensing ion channels (ASIC3) in health and simulated peripheral artery disease

PROJECT SUMMARY
Chronic ischemia in muscle (skeletal or cardiac) leads to accumulation of lactic acid and other inflammatory
metabolites with subsequent drop in interstitial pH. The ensuing tissue acidosis plays a major role in triggering
claudication (walking-induced pain) and chest pain. The high-affinity and selective mu opioid receptor (MOR)
agonists, endomorphins, are also released under ischemic and inflammatory conditions. Acid-sensing ion
channels (ASIC) are key players in the perception of pH changes associated with tissue acidosis,
inflammation and pain. ASIC are expressed highly in sensory (i.e. dorsal root ganglion, DRG) and central
neurons and are voltage-insensitive, depolarizing cationic channels. Endomorphin-1 (E-1) and -2 (E-2) are
tetrapeptides known to activate MOR and exert analgesic effects. However, our recent findings indicate that E-
1 and E-2 significantly potentiated the acid-induced ASIC3 currents in transfected fibroblast L-cells and in
acutely isolated DRG neurons independent of MOR activation. The potentiation by both opioids was
significantly greater in DRG neurons isolated from rats with ligated femoral arteries (peripheral artery disease
model). Importantly, our in vivo data demonstrated that E-2 significantly enhanced the lactic acid-induced
increase in mean arterial pressure in rats. The E-2-mediated enhancement was significantly attenuated by the
ASIC3 blocker, APETx2, but was insensitive to naloxone. Our long-term goal is to understand the
mechanisms by which endomorphins and clinically employed opiates (oxycodone, fentanyl, remifentanil)
modulate ASIC3 currents, the interacting site on the channel, and how they regulate the exercise pressor
reflex (EPR) which is evoked by muscle contraction. Our overall hypothesis is that chronic muscle
ischemia—accompanied by an acidified and inflamed environment, and enhanced ASIC3 expression—
elevates endomorphin release, leading to enhanced ASIC3 currents. The overall effect is hyperexcitability of
primary afferents that produces an exaggerated EPR. This hypothesis will be tested using complementary in
vitro and in vivo approaches. We will determine the biophysical and pharmacological effects of endomorphins
and prescription opiates on heterologously expressed ASIC3 in L-cells. We will identify ASIC3 channel
residues that functionally negate the actions of E-1 and E-2, but leave the basic physiology of the channel
intact. We also will compare the opioid agonist pharmacological profiles on ASIC channel currents in DRG
neurons from rats with “freely perfused” or “ligated” femoral arteries. We will examine the effects of E-1, E-2
and prescription opiates on the EPR evoked in both wild-type and ASIC3 knockout rats in which the femoral
arteries are “freely perfused” or “ligated”. Overall, these experiments will provide novel information about how
opioid peptides potentiate ASIC currents under ischemic conditions, thereby enhancing pressor responses to
exercise and possibly worsening pain associated with chronic use of prescription opiates (i.e., opioid-induced
hyperalgesia).

Public health relevance
PROJECT NARRATIVE In the current grant proposal, we will study how endogenous opioids (called endomorphins) and clinically employed opiates (such as fentanyl, remifentanil) regulate the entry of Na+ ions through acid sensing ion channels (ASIC) in rat sensory neurons. We will also investigate the ability of endomorphins to enhance blood pressure increases mediated by lactic acid and contracting muscle. We will employ rats with “freely perfused” femoral arteries and those that have had their femoral artery “ligated”—a model of peripheral artery disease.